The Tunicate Ciona: A New Model for the Effects of Aging on Tissue Regeneration

DESCRIPTION (provided by applicant): Many vertebrates have robust capacities for tissue regeneration as embryos and juveniles but this power fades during development and aging. The mechanisms of age-related decline in regenerative capacity are unknown and an area in which new approaches and model systems are necessary. This proposal develops the tunicate Ciona intestinalis as a chordate model for studying the effects of aging on tissue regeneration. Although not previously used as an aging model, Ciona has many favorable attributes for this purpose: it has powerful capacities for regeneration, which decline during aging, a sequenced genome, a collection of cDNA and ESTs covering 80% of the total genes, stable transgenic lines with tagged gene expression in specific tissues, and a short life history in which age is directly related to size. As a member of a chordate invertebrate group that is inferred to be the sister taxon of vertebrates, information obtained about the relationship between aging and regeneration in tunicates may be relevant to humans. The five specific aims of this proposal are designed to obtain a molecular and cellular understanding of defective oral siphon regeneration during aging. We will focus on the sensory pigment organs of the oral siphon, possible photoreceptors that regenerate with high fidelity in young and middle age animals, but show specific defects in old animals. The first three aims will focus on the cellular events involved in producing age-related defects in pigment organ regeneration. The first aim will investigate the effects of aging on maintenance of the stem/progenitor cell niche for pigment organ precursors and precursor cell migration to the wound site during regeneration. The second aim will focus on age-related changes in cell death and proliferation in the siphon wound site, the stem/precursor niche, and the reforming pigment organs during regeneration. The third aim explores the role of siphon nerves and the CNS in regenerative aging using ablation techniques and a transgenic line with GFP staining throughout the nervous system. The fourth and fifth aims investigate the molecular mechanisms responsible for age-related defects in pigment organ regeneration. The fourth aim will identify and determine the expression patterns of genes involved in regeneration, including components of the Notch signaling system, which preliminary studies have implicated in the regenerative process. The fifth aim will use RNAi gene silencing to establish how functional changes in regeneration genes are involved in the cellular aging processes revealed in the first three aims. This research is expected to fill a major gap in understanding how regenerative capacity declines with aging in a model chordate representing the closest living relative of vertebrates.

Public health relevance
PUBLIC HEALTH RELEVANCE: The ability to replace injured tissues fades with aging in most vertebrates, including humans. This study will develop the tunicate Ciona intestinalis, a vertebrate relative with powerful regeneration abilities that also recede with age, as a model to study the relationship between aging and tissue regeneration. 7. Project Narrative The ability to replace injured tissues fades with aging in most vertebrates, including humans. This study will develop the tunicate Ciona intestinalis, a vertebrate relative with powerful regeneration abilities that also recede with age, as a model to study the relationship between aging and tissue regeneration. __SpecificAimsTextDelimiter__ 2. Specific Aims. This proposal develops the tunicate Ciona intestinalis as an invertebrate chordate model to determine the molecular and cellular effects of aging on tissue repair and regeneration. Ciona has many favorable attributes for research in aging and regenerative biology: (1) a relatively short life cycle, (2) powerful regeneration capacities, (3) the appearance of a distinct set of regenerative defects during aging, (4) a small sequenced and annotated genome, (5) a large collection of expressed sequence tags (ESTs), and (6) the availability of transgenic animals expressing GFP in specific adult tissues. Furthermore, its phylogenetic position suggests that Ciona could be a relevant model for understanding why tissue regeneration capacities fade during vertebrate development and aging. Despite these attributes, molecular and cellular information on tissue regeneration and aging is virtually non-existent in Ciona. This proposal aims to close this gap by exploiting the tremendous potential of the Ciona model for understanding the relationship between aging and regeneration. Figure 1. A. Ciona intestinalis. B. Diagram of the oral siphon showing distally located orange pigment organs and underlying proximal zones demarcated by longitundinal and circular muscle fibers. C. Magnified view of the external face of a single orange pigment organ located in a notch between the siphon lobes and surrounded by a band of yellow pigment. D. Diagram of a sensory pigment organ in cross-section showing the receptor cells (RC) and orange pigment cup (PC). The Ciona pharyngeal complex, CNS (cerebral ganglion or brain), and oral and atrial siphons, which are equipped with pigmented sensory organs (Fig. 1), show high capacities for regeneration. Because of the ease in which they can be amputated, the speed and precision of their regeneration, and the existence of age related regenerative defects, the sensory pigment organs are the focus of this proposal. There are five specific aims that are designed to provide fundamental information on (1) the molecular and cellular control of sensory pigment organ regeneration and (2) the mechanisms responsible for defective regeneration during aging. Specific Aim 1. To determine the effects of aging on maintenance of the stem/progenitor cell niche and polarized migration of precursor cells during sensory pigment organ regeneration. This aim combines the use of microsurgery, explant culture methods, and pigment organ markers to determine if regenerative aging can be explained by recession of the stem/progenitor niche and/or changes in polarized cell migration to the wound site. Specific Aim 2. To determine the role of cell death and proliferation on age-related defects in sensory pigment organ regeneration. This aim uses markers for apoptosis and cell proliferation and inhibitors of these processes to investigate whether regenerative aging can be explained by changes in these key cellular processes. Specific Aim 3. To determine the role of the nervous system in age-related defects during sensory pigment organ regeneration. This objective employs transgenic Ciona with GTP expression throughout the nervous system and nerve and CNS ablation to determine whether regenerative aging involves changes in nervous system re-growth and function. Specific Aim 4. To identify and determine the expression patterns of candidate genes with potential roles in age related decay of sensory pigment organ regeneration. Screening of major signaling systems with small molecule antagonists, subtractive hybridization, and microarray analysis will be combined to identify genes involved in sensory pigment organ regeneration, and their expression patterns will be determined by in situ hybridization. The genes of the Notch signaling system, which has been implicated in sensory pigment organ regeneration, will be a focus of this aim. Specific Aim 5. To determine the function of genes involved in age-related decay of sensory pigment organ regeneration. RNAi will be used to systematically inhibit gene expression and determine its effects on the age-related defects in regneration identified in Specific Aims 1-3.